Mechanisms of glucose mediated cardiac mitochondrial dysfunction

Project Summary Heart failure is a major cause of death in individuals with diabetes. Heart failure is characterized in part by mitochondrial dysfunction defined by decreased oxidative capacity and ATP synthesis. Diabetes is accompanied by a number of systemic changes including hyperlipidemia and hyperglycemia. A critical barrier in determining the molecular mechanisms that lead to the development of diabetes-related complications has been the availability of appropriate in vivo models to test each independently. To define the role of glucose delivery to the heart in the regulation of mitochondrial function we have developed a mouse model for inducible cardiomyocyte-specific expression of the glucose transporter, GLUT4. Thus allowing us to directly test the role that cardiomyocyte glucose delivery plays in the healthy and diseased heart. Our preliminary data define a model whereby increased glucose delivery in the basal state enhances glucose utilization. In stark contrast, increased glucose delivery in the presence of hyperglycemia accelerates the development of mitochondrial dysfunction. The long-term goal of my research is to determine the mechanisms controlling mitochondrial metabolic function in the heart. In this proposal, we will start by investigating the role of glucose-mediated mitochondrial regulation by examining glucose-delivery regulated post-translational modification of mitochondrial proteins (Aim 1) and epigenetic control of oxidative phosphorylation (OXPHOS) gene expression (Aim 2). The latter process has recently received significant attention for its contribution to glycemic memory, defined as the impact that antecedent glucose concentrations have on persistently increasing the risk of diabetic complications independently of current levels of glycemic control. For Specific Aim 1, we will determine the mitochondrial proteins that are modified by the post-translational modification O-linked GlcNAcylation, which is increased with diabetes, and begin to explore the functional consequences of glucose delivery on mitochondrial oxidative capacity and enzymatic function. Studies outlined in Aim 2, will define the role of epigenetic modifications associated with changes in OXPHOS gene expression that are uniquely regulated by glucose. The initial K99 phase of this proposal will facilitate training in aspects of proteomics (2D-PAGE and mass spectroscopy) and epigenetics (histone modifications and DNA methylation). This additional training will provide me with the knowledge and skill set to independently carry out my immediate short-term goal of finding a tenure-track position (R00 phase), necessary to complete the proposal's aims and pursue my interests in defining molecular mechanisms of cardiac dysfunction. Collectively, the completion of these studies will provide fundamental insights into the mechanistic basis for glucose in the development of diabetic cardiomyopathy and mitochondrial dysfunction.

Public health relevance
Public Health Relevance Heart failure is characterized by a decline in mitochondrial oxidative capacity and is a major cause of death in individuals with diabetes. We have developed a novel mouse model for inducible cardiac specific overexpression of the glucose transporter 4 (GLUT4). These studies will determine the contribution of cellular glucose uptake in the development of mitochondrial dysfunction in the heart. __SpecificAimsTextDelimiter__ Specific Aims Heart failure is characterized by a decline in mitochondrial oxidative capacity and is a major cause of death in individuals with diabetes. Diabetes is characterized by hyperglycemia and hyperlipidemia, which likely contribute independently to the pathogenesis of mitochondrial dysfunction in the heart. To isolate the contribution of increased glucose uptake in the development of mitochondrial dysfunction in the heart, we have generated a transgenic mouse model of inducible overexpression of the glucose transporter 4 (mG4H). This model has several advantages; it is 1) cardiomyocyte specific, 2) independent of systemic changes, and 3) reversible. Transgene induction at ambient serum glucose concentrations enhances cellular glucose uptake and mitochondrial glucose oxidation. In contrast, when serum glucose was increased as a consequence of streptozotocin (STZ)-induced insulin deficiency, transgene induction accelerated the development of mitochondrial dysfunction leading to decreased ATP levels. Glucose regulates molecular processes by post-translational modifications such as GlcNAcylation (O-GlcNAc). Increased O-GlcNAc modifications have been shown to decrease the activity of oxidative phosphorylation (OXPHOS) enzymes such as Ndufa9. Cellular glucose also regulates gene expression by; 1) GlcNAcylation of transcription factors (e.g. Sp1) or 2) epigenetically by inducing histone and DNA modifications. The latter process has recently received significant attention for its contribution to "glycemic memory", defined as the impact that antecedent glucose concentrations have on persistently increasing the risk of diabetic complications independently of current levels of glycemic control. Our preliminary studies show that transgene induction alone (mG4H-Veh) altered the levels and O- GlcNAcylation on multiple mitochondrial proteins, including Ndufa9, to a similar degree as diabetes (Con-STZ). Microarray analysis revealed that 10% of the diabetes (Con-STZ) regulated nuclear encoded OXPHOS genes are regulated by mG4H-Veh alone. Thus defining a subset of the expression changes seen in diabetes as being directly mediated by glucose delivery. The mechanisms for these intriguing preliminary observations are unknown and will be a focus of this application examining OXPHOS genes that are uniquely regulated by glucose. The overall hypothesis to be tested by these studies is that cellular glucose delivery alters mitochondrial function via post-translational and transcriptional mechanisms. These studies will identify changes seen in the diabetic heart that are a direct consequence of increased exposure to glucose by 1) O-GlcNAcylation and 2) transcriptional and epigenetic mechanisms that may or may not be secondary to O-GlcNAc modifications. Specific Aim 1: To determine the mechanisms by which increased glucose delivery modifies the mitochondrial proteome. Cardiac mitochondrial function is altered in diabetes and occurs in part via post- translational modifications of OXPHOS proteins. To test the hypothesis that a subset of these changes is secondary to increased exposure to glucose or its metabolites, we will: 1) conduct quantitative proteomic analysis of mitochondrial proteins and determine the extent of O-GlcNAc modifications and 2) determine the impact of these modifications on OXPHOS activity and mitochondrial function. These studies will identify glucose dependent changes of mitochondrial proteins and determine their functional relevance. Specific Aim 2: To determine the mechanism by which glucose modulates nuclear pathways that regulate mitochondrial function. Glycemic memory has recently emerged as an important mechanism that contributes to cardiovascular complications of diabetes. This aim will test the hypothesis that glucose mediates specific epigenetic modifications that alters the transcriptional regulation of nuclear encoded mitochondrial OXPHOS genes. This will be achieved by examining 1) transcription factor activity, 2) histone modifications, and 3) DNA methylation. 4) The reversibility of transgene expression will enable us to identify those changes in gene expression that persist after transgene silencing further defining the contribution of "glycemic memory". These studies will provide novel information regarding the regulation of the mitochondrial proteome by glucose, and define the functional consequences of these changes. The identification of these targets will have implications for developing novel therapeutic approaches, and will provide targets and reagents that will form the basis for future R01 proposals examining the mechanisms by which glucose alters cardiac function by impairing mitochondrial function.